Comparative Pathology Core

Vertebrate animal model use is essential to answer fundamental questions and elucidate the mechanisms in
vivo through which environmental exposures may influence human disease and produce adverse human
health outcomes. Diverse animal models, such as zebrafish, medaka fish, mouse, rat, rabbit, guinea pig, vole,
xenopus, domestic animal (dogs, pigs, sheep, etc.) and others, along with their genetically engineered
counterparts, represent powerful in vivo approaches to link molecular mechanisms to pathologic lesions
(disrupted organ/tissue function) and toxic effects. Animal models remain the gold standard for studying these
effects of environmental toxicants on development, cancer, reproduction, organ toxicity, and neurological and
endocrine systems. These approaches are powerful because in vivo model organisms operate in a systems
biology framework integrating all levels of biological organization - biomolecule, pathway, cell, tissue, organ,
and organism - and inform us of potential adverse human health outcomes. Understanding these adverse
effects requires expert pathologic evaluation of the affected tissue/organ/cells. To fill this need, the mission of
the Comparative Pathology Core (CPC) is to provide CHHE member scientists dedicated access to cost-free
pathology expertise to assess the effects of environmental factors in a diverse range of animal models.